MATERNAL VITAMIN D STATUS AND MEASURES OF NEONATAL BONE MINERAL CONT

The tasks to utilize this contract are to analyze samples from the Calcium for Preeclampsia Prevention trial (CPEP) to measure total 25(0H)D, its isoforms (25(0H)D2 and 25(0H)D3), Vitamin D binding protein (VDBP), albumin, and total calcium in up to 992 serum samples from the CPEP trial. Period of performance for this task is estimated to be 6 months. The purpose of this Task Order is to investigate the Maternal Vitamin D Status and Measures of Neonatal Bone Mineral Content/Density, Body Fat, and Birth Weight in CPEP.